Translational Research in Cancer

DESCRIPTION (provided by applicant): This proposal for a Cancer Center Support Grant (CCSG) requests funding to support the cancer research activities of the Kimmel Cancer Center (KCC), in order to increase the survival and quality of life of cancer patients by translating basic research discoveries into new strategies to prevent, diagnose, monitor and cure human cancer. The major thrust of the Kimmel Cancer Center is in discovery and translation of the latest findings in the genetics, cell biology, biochemistry and immunology of cancer into novel modalities to cure cancer. [unreadable] [unreadable] The Kimmel Cancer Center consists of six programs and thirteen shared resources to support the research programs. Investigators in each program are involved in intra-programmatic and inter-programmatic collaborations and have been extremely successful in obtaining peer-reviewed funding for these collaborative studies. The environment within the KCC has facilitated numerous collaborative studies and publications that have contributed to important advances in cancer research. [unreadable] [unreadable] The KCC programs are supported by sponsored funding. Funding comes from 73 NCI sponsored projects, including 2 inter-programmatic NCI program project grants. The efforts of the Director and his recruits have resulted in increased philanthropic University and Hospital support. The importance of cancer research and care at Thomas Jefferson University is reflected in the Director's authority over clinical and research activities at the Institution, encompassing 144,208 sq. ft, and the construction of new facilities (232,114 sq. ft) including the new Breast Center, Oncology Center and research space. These new facilities will accommodate the basic, clinical and translational efforts of the KCC investigators. These new KCC facilities will enhance even further the translational cancer research effort of the Kimmel Cancer Center. [unreadable] [unreadable]